Harnessing Artificial Intelligence and Deep Learning to Determine a Coronary Artery Calcium Estimate in Patients with No History of AtheroSclerotic CardioVascular Disease (HIDDEN-ASCVD) Study

PROJECT SUMMARY/ ABSTRACT
Data science advances have led to the emergence of opportunistic imaging screening – applying algorithms to
screen for conditions from imaging performed for other purposes. Opportunistic screening for coronary artery
calcium (CAC) is an ideal test case. CAC is the strongest predictor of atherosclerotic cardiovascular disease
(ASCVD) and knowing one has CAC can be a powerful motivator of preventive behavior. However, <1% of
potentially eligible patients receive electrocardiogram (ECG)-gated computed tomography (CT) scans to
measure CAC. CAC can be identified on non-gated chest CTs, of which 19 million are performed annually in
the U.S. We previously demonstrated that a deep learning (DL) algorithm can accurately quantify CAC on non-
gated, non-contrast chest CTs, and notifying patients and providers of the presence of opportunistic CAC
significantly increased statin prescription rates compared to usual care. The HIDDEN-ASCVD study will extend
validated DL-CAC methods to non-cardiac, contrast-enhanced CT scans and include a factorial randomized
controlled trial (RCT) to identify the optimal opportunistic CAC notification strategies to maximize statin
prescription rates and patient and provider acceptability within Kaiser Permanente Northern California, an
integrated health system providing care to >4.5 million members with broad racial and ethnic diversity. In Aim
1, we will validate the diagnostic accuracy of the existing DL-CAC algorithm and adapt the algorithm to
contrast-enhanced CT scans using self-supervised DL and paired non-gated and gated CT scans. We will also
describe the epidemiology and outcomes of opportunistic CAC in this diverse health care system. In Aim 2, we
will identify 5,760 adults with DL-CAC on chest CT, without known ASCVD, and not receiving statins and
efficiently test multiple notification strategies based on the MINDSPACE behavior change principles and the
Multiphase Optimization Strategy (MOST) framework for intervention optimization. Through a factorial RCT
design, we will determine the most effective notification strategy that maximizes statin therapy and minimizes
patient-reported anxiety. Co-design focus groups of providers and patients that received notifications will then
provide input on serial adaptation of the strategy based on their experience. The adapted optimal strategy will
be tested in a single-arm validation study to determine an unbiased estimate of the net effect of the
intervention on statin initiation and patient acceptability. The RCTs will be enriched for historically marginalized
racial and ethnic groups to provide generalizable knowledge. The HIDDEN-ASCVD study will be paradigm
shifting by identifying the optimal behavioral science-driven notification strategy for opportunistic CAC
balancing the benefit of statin therapy with the perceived risks of health-related anxiety. This research will
motivate future studies designed to implement opportunistic CAC screening and notification on a health
system-wide scale reducing the overall burden of ASCVD and mitigating documented health disparities.

Public health relevance
PROJECT NARRATIVE This study will use an artificial intelligence computer program (i.e., an “algorithm”) to read thousands of computed tomography (CT) scans that have already been done to look for calcium deposits in heart arteries. The study will (1) modify the existing program to work on CT scans with contrast dye, (2) describe the people with calcium deposits in a contemporary and diverse population, and (3) compare different types of messages for notifying patients about their calcium deposits to see which approach is the most acceptable to patients and their primary care providers and most effective at getting the patient to start a risk-lowering statin medicine. If the algorithm and notification messages are effective, this method could be used to find people who do not know about their risk and help them take steps to prevent heart attacks and strokes.